Determining molecular mechanisms of damage and repair in an oral mucosa chip

7. Project Summary/Abstract
Oral mucositis is a painful, treatment-modifying side effect of cancer therapy that affects roughly 50% of cancer
patients annually in the United States. Currently, the only FDA-approved drug to treat oral mucositis, palifermin,
is used in only about 4% of clinical cases. The long-term objectives of this project are to elucidate molecular
mechanisms of damage initiation in mucositis, including pro-inflammatory cytokines, and the timing of cell-
specific events, and also to facilitate the discovery and translation of new anti-mucositis drug candidates. These
discoveries will be achieved by experiments on a novel mucosa chip platform representing the epithelial and
subepithelial layers of the oral mucosa. This project is expected to directly support high-throughput on-chip
testing of single and combination oral mucositis therapies and also a future, personalized medicine approach for
treating oral mucositis in cancer patients, using information from the patients’ own cells and saliva.
This proposal aims to (1) determine the effects of cisplatin and 5-fluorouracil treatments mirroring the pre-clinical
and clinical administration schedule of three separate infusions, with evaluations of cell layer morphology,
reactive oxygen, pro-inflammatory cytokines, cell proliferation, and cell death. Effects of fractionated radiotherapy
will also be evaluated on the chip, extending previous findings that used single-dose therapy. A second aim (2)
will determine single and synergistic effects of putative anti-mucositis drugs: a superoxide dismutase mimetic, a
defensin-mimetic, and two interleukin inhibitors. These reagents are applied clinically via intravenous infusion or
by topical rinse, respectively, so they will be applied to both peripheral channels of the mucosa chip, with the
same cell and molecular endpoints. Achievement of Aims 1 and 2 will involve performing microscopy assays,
ELISAs, antibody arrays, fluorescence wellplate and imaging assays, and RNA sequencing. Specific molecular
endpoints will include activation, expression and nuclear translocation of transcription factors Nrf-2 and NF-κB;
expression of numerous pro-inflammatory cytokines including TNF-α, IL-1 α,β, IL-2, -3, -6, and -13, among
others; and intracellular plus live-cell reactive oxygen species assays. Dose-response studies will be conducted
for chemotherapy and anti-mucositis agents applied singly before combination treatments on the mucosa chip.
The health-relatedness of this proposal lies in directly impacting oral health and supporting development
of precision medicine approaches through knowledge of oral mucositis and the effects of treatments in vitro. The
proposed systems could test novel anti-mucositis drug candidates in parallel with pre-clinical tests. Such
knowledge would potentially lead to more successes at the level of clinical trials targeting oral mucositis
interventions. This approach is particularly effective as anti-mucositis drugs with poor performance or with
unacceptable side effects can be identified and abandoned before costly pre-clinical and clinical trials.

Public health relevance
8. Project Narrative New successful anti-mucositis drugs must effectively reduce pro-inflammatory signals and cell damage in the oral mucosa without promoting cancer progression or inhibiting cancer treatments. To address this, novel in vitro mucositis models will be used to test cell and molecular responses to several proposed mucositis therapeutic agents. These cell and molecular responses will be assessed and compared to determine mechanisms of action and potential synergistic effects. Fundamental knowledge gained from this work will identify potential novel targets for anti-mucositis drugs and evaluate the drugs’ potential in the clinic, providing information helpful for preclinical research and clinical trials.